Physical Biochemistry Of Macromolecules

The purpose of this project is the collaborative study of the physical properties of a wide variety of biological macromolecules with the goal of correlating these properties with the structure and function of the macromolecules. Analytical ultracentrifugation and mathematical modeling are the principal research techniques used. An area of major emphasis has been collaborative studies with the laboratory of Dr. Samuel Wilson (NIEHS) on proteins involved in DNA transcription initiation and in DNA repair. Studies in progress are (1) the interactions between DNA Ligase I and the replication protein, proliferating cell nuclear antigen (PCNA); (2) the interaction mechanisms between the XRCC1(1-183) protein and DNA polymerase-beta and its subdomains; (3) the study of DNA transcription initiation repression by gal repressor (galR) and the HU protein; and (4) the interactions between AP endonuclease and DNA, DNA polymerase-beta and DNA, and both together with DNA. Research has been completed on two aspects of the studies on DNA enzymes, the thermodynamics of oligomerization of PCNA and the interaction of PCNA with histidine-tagged and untagged FEN-1. Two manuscripts are in preparation. Studies on the associative behavior of translin, a protein involved in translocation of chromosomal DNA, have been done in a collaboration with Dr. Jay Knutson (NHLBI) and Dr. Myun Ki Han (Pioneer Biotechnology). New studies on translin clearly demonstrated that the prior studies which suggested that translin undergoes a monomer-octamer reversible association were in error. Translin octamer was isolated and it was definitively established that the octamer did not dissociate and that the octameric form bound single-stranded DNA. These studies utilized the newly developed technique of multi-wavelength analysis where one or more of the interacting components has an added chromophore label that permits observing the specific behavior of the labeled component. (See Project 1Z01 OD10039-07, "Biophysical Instrumentation and Methodology.") In addition, a collaborative investigation of the thermodynamics of the self-association of HIV-1 integrase and the effects of DNA binding on this association are also under way using this new technology, with Drs. Knutson (NHLBI) and Han and Harvey (Pioneer Biotechnology). Two manuscripts are in preparation on the work done collaboratively with Dr. Wilson's laboratory.